Interrogate the interaction between tumor cells and nerves in the tumor microenvironment of pancreatic cancer

Summary
This is a competitive renewal of the originally funded R01 that was focused on dissecting Annexin A2 mediated
mechanisms for the invasion and metastasis of pancreatic ductal adenocarcinoma (PDAC). PDAC is one of the
major causes of death from malignant diseases. The poor prognosis of PDAC is attributed to early onset of
metastasis and lack of effective treatments for PDACs. The tumor microenvironment (TME) of PDAC is
believed to hold a key for overcoming the challenge of treating PDAC. Previously, we showed that tyrosine
phosphorylation of Annexin A2 is essential for PDAC invasion and metastasis. We further discovered that
Annexin A2 controls the secretion of Semaphorin 3D (Sema3D) and the autocrine effect of Sema3D on PDAC
invasion and metastasis through binding to its receptor, Plexin D1/Neuropilin-1 (PlxnD1/NrP1). Interestingly,
Sema3D, PlxnD1, and NrP1 all belong to the nerve axon guidance protein family, which is among the most
frequently altered gene families in PDACs. The neuronal component of the TME in PDACs cannot be
negligible as perineural invasion (PNI) is an important pathological characteristic in many malignancies,
particularly PDAC. Semaphorins and plexins have also been implicated to regulate immune functions by
controlling differentiation and trafficking of macrophages. Accumulated evidence has suggested that
macrophages promote the development of the acinar to ductal metaplasia (ADM), which is thought to be a
mechanism underlying the initiation of PDACs. Therefore, we propose to test the hypothesis that the
interaction between the tumor cells and nerves plays an essential role in promoting ADM, growth, invasion,
and metastasis of PDAC. First, this new project will dissect a paracrine Sema3D-PlxnD1 signaling pathway
that mediates the PNI and subsequent metastasis of PDAC. Second, the project will study the nerve-derived
Sema3D in controlling PDAC development through the PlxnD1 receptor on tumor cells in a mutant Kras-
dependent manner. It will examine whether the Warburg effect induced by the Sema3D/PlxnD1-mutant Kras-
ARF-GTP signaling cascade will affect the function of macrophages in vitro and whether tumor associated
macrophages (TAM) will be reprogrammed in vivo when Sema3D is tissue-specifically knocked out from
sensory nerves. Third, this project will investigate the role of Sema3D and the genetic alterations of the axon
guidance pathway in vivo in pro-cancerous inflammatory response and PDAC development in both mouse
models of PDAC and human PDAC specimens. The relationship between the expression of axon guidance
molecules in pancreatic premalignant and malignant epithelia, in intra-pancreatic nerves, and in immune cells
and the quantity and distribution of macrophages and other immune cells will be assessed.
1

Public health relevance
Project Narrative Peri-neural invasion is an important pathological characteristic in many malignancies, particularly pancreatic cancer. Previous reports have also suggested that nerves play a central role in promoting the inflammatory process in the pancreas. Therefore, this project will investigate the mechanistic basis underlying the interaction between the tumor cells and nerves and interrogate how this molecular mechanism controls pro-cancerous inflammatory process and promotes the growth, invasion, and metastasis of pancreatic cancer.